CRCNS: Diverse effects of GABAergic inputs on a basal ganglia output center

The basal ganglia are a collection of subcortical nuclei studied for their contributions to movement, action
selection, habit formation, and reward learning as well as their dysfunction in movement disorders. While
basal ganglia processing of cortical inputs and the emergence of the direct and indirect pathway
communication channels within the striatum have been the subject of extensive investigation, the
integration of these channels at the level of basal ganglia output nuclei including the substantia nigra pars
reticulata (SNr) has been relatively understudied. This imbalance is problematic for our understanding of
basal ganglia function, because basal ganglia impacts on other areas of the nervous system, and hence on
behavior, are funneled through basal ganglia output nuclei and depend on how they process the signals
they receive. This project will build on and test ideas recently proposed based on computational and
experimental work from the PIs’ groups to investigate SNr activity in ways that redress this knowledge gap.
Specifically, this work will advance our knowledge about: how SNr neuron responses to GABAergic inputs
from a major source, the external segment of the globus pallidus (GPe) in the indirect pathway depend on
SNr neuron characteristics, the locomotor state of the subject, and dopamine levels; how they are expected
to impact dynamics at the level of the SNr network and its outputs; the extent to which chloride dynamics
and its effect on the GABA reversal potential give rise to these behaviors; and how these factors contribute
to the delta band oscillations that emerge in SNr specifically under dopamine depletion. These advances
will be achieved via an interdisciplinary approach of model development, simulations, and analysis done in
synergy with experiments in slice and in vivo in mice involving optogenetics, neural recording,
pharmacological manipulations, and behavior across control and dopamine-depleted conditions.
RELEVANCE (See instructions):
Basal ganglia dysfunction contributes to a range of disorders including Parkinson’s disease, which is characterized by significant
dopamine depletion. The proposed research will provide new insights about how dopamine depletion alters communication
among key neural populations within the basal ganglia, as well as output signaling from the basal ganglia, which can impact
motor behavior. These findings will supply information that is of direct utility in the search for therapeutic targets and the
development of efficient, effective brain stimulation paradigms to reduce the motor complications of Parkinson’s disease.